MECHANOSURVEILLANCE IN BREAST CANCER METASTASIS

PROJECT SUMMARY/ABSTRACT - MECHANOSURVEILLANCE IN BREAST CANCER METASTASIS
Metastatic breast cancer is a devastating disease that impacts the lives of tens of thousands of women each
year. Unfortunately, the majority of treatment options for patients diagnosed with metastatic breast cancer are
palliative. Current treatment strategies often target cancer cells’ genetic and biochemical abnormalities, but
cancer cells also undergo profound changes in their biophysical properties such as cellular stiffness. Targeting
biophysical properties offers exciting new therapeutic avenues, but the basic knowledge on the relationship
between cancer cell stiffness and regulation of metastasis is incomplete. Emerging evidence suggests that
cancer cell stiffness acts as a mechanical input for activation of cytotoxic lymphocytes that destroy cancer
cells. Thereby, stiffness becomes an immune vulnerability of cancer cells during the metastatic cascade. This
process, where mechanical inputs activate the immune surveillance, is termed mechanosurveillance and it is
strongly regulated by the expression of Myocardin related transcription factors A and B (MRTFA/B) in cancer
cells. Based on the published and the preliminary data, the overarching hypothesis of this project is that
MRTFA driven calcium influx increases cancer cell stiffness and thereby activates mechanosurveillance during
breast cancer metastasis. The long-term goal of this project is to determine the molecular mediators of MRTFA
associated mechanosurveillance and thereby inform pharmacological methods to exploit this cancer cell
vulnerability for better treatment of patients with metastatic breast cancer. The research design includes a set
of interdisciplinary approaches, such as transcriptomic and genomic analyses of patient samples and cancer
models, atomic force microscopy on patient derived xenograft organoids (PDXos) and on immunocompetent
models of metastatic colonization, and histological analyses of human breast cancer metastases. The specific
aims of this project are:
1) to determine the contribution of MRTFA driven calcium influx on cancer cell stiffness in PDXos, in
vitro, and in situ mouse models by using atomic force microscopy and confocal microscopy.
2) to determine the degree of cytotoxic lymphocyte activation by MRTFA and the associated stiffness
in vivo by using multiplexed imaging and machine learning on metastatic tissue samples from patients and
by using flow cytometry in metastases in syngeneic mouse models.
3) to determine how to exploit MRTFA associated mechanosurveillance to target metastases by testing
the impact of clinically relevant immune checkpoint blockade treatments on metastasis bearing mice.
This work will uncover mediators of mechanosurveillance and demonstrate its prevalence in human cancer.
Thus, results of this work will impact the immediate use of immune checkpoint blockade and the future
strategies to enhance mechanosurveillance in patients with metastatic breast cancer.

Public health relevance
PROJECT NARRATIVE - MECHANOSURVEILLANCE IN BREAST CANCER METASTASIS Metastasis is the leading cause of breast cancer related deaths, but the majority of treatment options that target known abnormalities in cancer cells are not curative. In our effort to identify additional abnormalities in cancer cells for therapeutic targeting, we found that the immune system could sense and destroy cancer cells based on cancer cells’ altered biophysical stiffness. In this project, we aim to close the knowledge gap in our molecular understanding of this novel mode of immune surveillance, which we termed mechanosurveillance, in order to facilitate clinical progress in metastatic breast cancer treatment.